Respiration and Generalized Epilepsies

Project Summary
Spike-Wave Discharges (SWDs) are a common type of seizure in the Genetic Generalized Epilepsies (GGEs).
Hyperventilation triggers SWDs in the overwhelming majority of patients with absence epilepsy, the most
common form of pediatric GGE. We have recently developed a rodent epilepsy model wherein we can evoke a
burst of SWDs with hyperventilation. Within 6 minutes of hyperventilation, SWD count increases by over 500%.
We now leverage this model to gain unprecedented access to core seizure-generating mechanisms associated
with SWDs.
By combining plethysmography, EEG and blood measurements in single animals, we show that SWD circuits
appear critically sensitive to blood pH. First, we show that hypoxia, a condition that activates hyperventilation,
robustly evokes rodent SWDs. Hypoxia-induced hyperventilation results in increased exhalation of CO2 and
concomitant blood alkalization (i.e. respiratory alkalosis). We also show that hypoxia-evoked SWDs are
abolished when atmospheric CO2 is elevated, thereby supporting the hypothesis that blood alkalization drives
hyperventilation-evoked SWDs. Finally, we also show that optogenetic activation of hyperventilation during
normal atmospheric conditions – an experimental procedure that reduces blood CO2 but increases O2 – also
evokes SWDs. Thus, collectively our data show that SWDs appear to primarily covary with blood CO2.
We complement our plethysmography-EEG data with brain slice electrophysiology and calcium imaging. We
focus our attention on the intralaminar nuclei of the thalamus because activity-dependent cell tagging
approaches (i.e. cFos) consistently label cells within this region after hypoxia-induced hyperventilation. By using
whole-cell patch clamp recording techniques we demonstrate that intralaminar thalamic cells produce
depolarizing ionic currents during alkalized conditions. A significant portion of this current appears to be mediated
by enhanced excitatory synaptic drive.
With our preliminary data, we now present a project that aims to test the overarching hypothesis that activation
of pH-sensitive intralaminar thalamic neurons by acute respiratory alkalosis precipitates absence
seizures. Identifying these neurons and their mechanisms of activation will inform new strategies to treat the
most common pediatric GGEs, disorders for which only decades-old, sub-optimal treatments exist. We
specifically test the following main hypotheses:
 Aim 1 Respiratory alkalosis triggers absence seizures.
 Aim 2 Spontaneous and hyperventilation-triggered seizures utilize the same neural ciruitry.
When complete, we expect that the results of our project will provide significant, new insights into fundamental
cellular- and circuit-level mechanisms that drive generalized spike-wave discharges, and therefore pave new
avenues for generalized epilepsy treatments.

Public health relevance
Project Narrative Generalized seizures are brain-wide events and occur in several types of epilepsy. Asking a patient to hyperventilate is a reliable strategy to diagnose generalized absence seizures – rapid breathing triggers a seizure in nearly 100% of patients. Identifying the biological processes that intimately link respiration and generalized seizures will lead to a better understanding of how the brain triggers seizures and will pave the way forward in developing better treatments.